Causal variant association mechanisms in TCF21 binding coronary disease loci

Building on the extensive genome wide association studies (GWAS) of coronary artery disease (CAD), and
single cell characterization of atherosclerosis, we have shown that the smooth muscle cell (SMC) lineage
harbors much of the risk for vascular disease. Further, these data indicate that SMC can assume two disease-
related transition states linked to disease risk. We identified TCF21 as a protective CAD GWAS gene and
showed that it regulates a disease-related transition of medial SMC to a fibroblast-like phenotype, producing
cells we term “fibromyocytes” (FMC). Further, we and others have found that SMC can also transition to a
second phenotype, characterized by expression of genes known for their role in endochondral bone formation
and intimal vascular calcification. Mouse genetic models have indicated that this chondrogenic process, which
gives rise to cells we term “chondromyocytes” (CMC), is promoted by CAD GWAS causal factors Pdgfd and
Twist1, and actively inhibited by protective TCF21 target CAD GWAS signaling molecules ZEB2 and SMAD3.
Further, recent transcriptomic and epigenomic (multi-ome) single cell studies indicate that FMC and CMC are
the end products of independent trajectories that SMC can differentially traverse in the disease setting. We
thus hypothesize that CAD protective GWAS genes TCF21 and ZEB2 promote disease protective FMC
and inhibit disease promoting CMC trajectories through regulation of critical enhancers and their
regulatory transcription factors (TFs) that underlie the fundamental mechanisms of CAD genetic risk in
the SMC lineage. Algorithms that link disease variation and disease transcriptomic data at the whole genome
level show that disease genetic risk resides in the cell state changes from SMC to FMC and SMC to CMC. We
now propose to investigate the enhancers, related TFs and their target genes (regulons) that mediate these
phenotype transitions, through the following Aims. In Aim 1, we will perform time-course studies with mouse
disease models targeted for disease inhibiting CAD associated genes Tcf21 and Zeb2 to map the cis- and
trans-acting factors and disease-related regulons that determine the disease trajectories and directionality of
disease risk. Findings from these studies will be mapped onto multi-omic single cell assay data of human
coronary lesions to establish that orthologous enhancers and molecular SMC mechanisms mediate phenotype
transitions in human disease. In Aim 2, we will address the hypothesis that over-expression of Tcf21 in medial
SMC will promote increased transition to the FMC phenotype, as indicated by epigenetic and gene regulatory
network modules, as well as increased fibrous cap formation and additional risk protective features. In Aim 3,
CRISPRi PerturbSeq experiments in human coronary artery smooth muscle cells will validate the results from
previous Aims, and further characterize downstream enhancers, related TFs, and regulatory networks. The
proposed studies will identify cellular and molecular mechanisms that mediate SMC transitions to FMC and
CMC, and the relationship of these transitions to vascular calcification and disease risk.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance) Significant expense and effort by groups of scientists around the world has identified regions of the human genome that are associated with the genetic risk for various forms of cardiovascular disease, including coronary artery disease. Additional research is required to understand the specific genes involved, and how they work to contribute to the disease process. Such information will allow for better risk assessment and the development of better therapeutics for these diseases.